Harnessing targeted IL-2 to reduce immunopathology and enhance immunity against respiratory virus infection

Influenza A virus (IAV) remains a global health concern despite annual vaccination efforts. Clinical interventions
able to prevent the immunopathology and `cytokine storm' associated with severe IAV infection are urgently
needed, especially approaches that can be initiated at later stages of infection. The knowledge gained from the
proposed studies will facilitate the development of a novel application of an IL-2-based therapeutic approach to
treat severe respiratory viral infection, as well as advance its potential use as an adjuvant to boost universal,
IAV-specific immunity following vaccination.

Public health relevance
Influenza A virus (IAV) remains a significant public health concern despite widespread vaccination efforts. Certain individuals are highly susceptible to infection and suffer from serious disease requiring hospitalization. Serious influenza is often associated with the development of an acute respiratory distress syndrome (ARDS) characterized by an uncontrolled inflammatory `cytokine storm' and severely compromised lung function that can be fatal. Current treatments for severe IAV and ARDS are limited to the use of high doses of antivirals, such as Oseltamivir phosphate (tradename Tamiflu) that is most effective when given early during infection, and invasive ventilation, which can double the risk of death. Innovative clinical interventions able to prevent severe respiratory virus infection are urgently needed, especially approaches that can be initiated at later stages of infection. Herein, using a preclinical murine IAV infection model, we will determine key mechanistic underpinnings of a novel application of an interleukin-2-(IL-2) based therapeutic approach that directly (i) promotes pathways to temper inflammation and improve tissue integrity while (ii) concomitantly, also, enhances anti-viral immunity. This proposal is based on our recent observations that directing IL-2 towards the high affinity CD25 subunit of the IL-2 receptor during IAV infection significantly reduces lung immunopathology and improves infection outcomes even when treatment is initiated on day 4 post infection. In addition to promoting expansion of Foxp3+ CD4+ regulatory T cells (T regs), as has often been reported in studies of CD25-targeted IL-2 treatment, we find that innate lymphoid cells (ILC) involved in tissue repair and activated anti-viral T cells, which both also express CD25, are mobilized with treatment. Our findings support that CD25-targeted IL-2 can simultaneously shape both anti- and pro-inflammatory responses during respiratory viral infection. Finally, we also find improved establishment of memory CD4 T cells following infection and treatment, indicating an adjuvant-like quality of this therapeutic approach. The first aim of this proposal will explore how to best utilize this intervention to improve the outcomes of severe IAV infection, in part, by revealing mechanistic insights into how deleterious inflammatory responses arise during serious IAV infection. Our second aim will delineate the role of T regs, ILC, and activated, anti-viral immune cells, in the regulation of IAV infection induced immunopathology and inflammation following CD25-targeted IL-2 treatment. Lastly, the third aim will investigate in depth the persistence and protective functions of IAV-specific immune memory induced in the presence of CD25-targeted IL-2 by IAV infection and vaccination. The insights gained from these studies will advance the development of this IL-2-based therapeutic approach as a treatment for severe respiratory viral infection, as well facilitate its potential use as an adjuvant to boost universal, IAV-specific immunity following vaccination.